Genomic Imprinting in the Development of NAFLD

ABSTRACT – Genomic Imprinting in the Development of NAFLD
By 2030, non-alcoholic fatty liver disease (NAFLD) is projected to affect more than 100 million
Americans, including 10 million children. NAFLD results from overaccumulation of fat in the liver and
can progress to non-alcoholic steatohepatitis and cirrhosis, leading to significant morbidity and mortality
even among children and adolescents. Accumulating evidence indicates that early life exposures alter
gene expression and influence the risk for NAFLD, but regions of the genome targeted by these
exposures remain unclear. We hypothesize that aberrant methylation at imprint control regions (ICRs),
discrete loci which regulate expression of specific genes and the function of gene networks, contributes
substantially to NAFLD. Measuring the impact of epigenetic modifications that alter NAFLD risk has
been challenging due to the lack of tools for comprehensive measurement of epigenetic modifications,
longitudinal data, cohort diversity, accurate non-invasive markers of liver fat and fibrosis, as well as the
temporal ambiguity between exposure and outcomes. To overcome these obstacles, we have
comprehensively identified DNA methylation-controlled regulatory regions for genomically imprinted
genes, many of which are implicated in metabolic disease, growth and development. Once established
in the gametes, these ICRs are stably transmitted during mitotic cell division and are thus very similar
across tissues. Importantly, imprinted genes play key roles in growth and metabolism, underscoring
plausibility in the etiology of NAFLD. The overarching goal is to utilize these novel ICRs to identify
methylation changes associated with NAFLD development. We will leverage the resources of our multi-
ethnic, pre-birth, longitudinal cohort, the Newborn Epigenetics STudy (NEST) to evaluate the oldest
500 children (17-21 years). We will identify ICRs at birth associated with increased liver fat, NAFLD,
and liver fibrosis using magnetic resonance imaging as well as intermediate markers of NAFLD and
metabolic dysfunction. ICR methylation will be examined in relation to metabolic outcomes, sex,
ethnicity and early life exposures. A 1-year follow-up of 200 adolescents will determine stability of the
associations. Finally, we will validate the ICR status of NAFLD-associated genes in different tissue
types to determine their ability to serve as early markers of disease risk. This proposal will contribute
significantly to knowledge on the relationship between genomic imprinting and NAFLD and clarify risk-
mediating regions and exposures that can be used to develop early detection and therapeutic tools to
combat the NAFLD epidemic.

Public health relevance
PROJECT NARRATIVE The association between early life exposures and development of non-alcoholic fatty liver disease (NAFLD) in children and young adults may be mediated by epigenetic mechanisms; however, the specific epigenetic modifications implicated in NAFLD risk remain largely unknown. We recently identified 1,488 novel putative human imprinted gene control regions throughout the genome and our goal is to identify aberrant methylation in those imprint control regions that is associated with the development of NAFLD. We propose one of the most rigorous investigations of this association, leveraging a large, multi-ethnic birth cohort with longitudinal data and specimens from birth to young adulthood, state of the art imaging of liver fat content and fibrosis, and a novel array able to systematically measure methylation at all imprint control regions – mechanistically linking early life to NAFLD and laying the foundation for improved early detection.